From inhibitors to enzymatic deficiencies: exploring alterations in erythrocyte glycolysis as an antimalarial strategy.

Project Summary/Abstract
The malaria parasite Plasmodium falciparum is responsible for millions of cases of malaria and over 500,000
global deaths each year. Resistance to current first-line antimalarial regimens, artemisinin-based therapies, is
spreading in Southeast Asia and Africa. This continued spread threatens current malaria control and eradication
efforts, and new antimalarials with novel mechanisms of action are urgently needed. All currently approved
antimalarials target parasite-specific enzymes and pathways. Host-directed therapies, which target host proteins
or pathways that are essential to the parasite, could serve as a novel antimalarial strategy. Determining the role
of host pathways in the parasite lifecycle will inform future host-targeting antimalarial drug development.
This project aims to determine the role of erythrocyte glycolysis in the Plasmodium falciparum intraerythrocytic
lifecycle. In Specific Aim 1, the candidate will inhibit glycolysis in terminal erythrocytes and determine how this
disruption affects P. falciparum growth, progression through the lifecycle, and susceptibility to oxidative stress.
In Specific Aim 2, the candidate will use gene editing to generate pyruvate kinase-deficient erythrocytes and
examine how prolonged disruptions in glycolysis affect the parasite. The results of the proposed experiments will
yield a comprehensive understanding of why erythrocyte glycolysis is essential to the P. falciparum
intraerythrocytic lifecycle and establish its tractability as an antimalarial target.
The candidate is a pediatric infectious diseases specialist committed to studying host-parasite interactions in
malaria parasites. The proposed training and research project will be conducted at the Children’s Hospital of
Philadelphia (CHOP) and the University of Pennsylvania (UPenn). These two institutions are leaders in the study
of host-pathogen interactions and erythrocyte biology and development and provide an ideal environment for the
proposed research and career development. The candidate will be mentored by Dr. Audrey John with the support
of an experienced and diverse advisory committee, including Drs. Stella Chou, Stefano Rivella, Akhil Vaidya,
and Sarah Tishkoff. The candidate’s long-term goal is to develop a research program that examines host-parasite
interactions in malaria infection and leverages these interactions to identify potential antimalarial targets and
develop therapies. Completion of the proposed research and career development will provide a strong foundation
for the candidate’s future career.

Public health relevance
Project Narrative Malaria represents an ongoing threat to global public health, and new antimalarial therapies are urgently needed. Malaria parasites infect red blood cells, and red blood cell glycolysis is required for the parasites’ lifecycle. This proposal examines the role of red blood cell glycolysis in the parasite lifecycle to determine if this host cell pathway could serve as a target for new antimalarial drugs.